HIV Database for HIV - AIDS Therapeutics and Microbicides

To provide the management of chemical and biological databases which serve as tools for the rational selection and discovery of potential therapies for AIDS and opportunistic infections (OIs). Databases will contain pertinent published literature and NIAID confidential data and information on the chemical, virological, immunological and microbiological aspects of therapeutic agents for HIV, OIs, and TB, and on microbicides.